Team-Based Design and Clinical Immersion Enhancements to the ASU Biomedical Engineering Design Education Program

Project Summary
The long-term goal of the proposed Team-Based Design and Clinical Immersion Enhancements
to the ASU Biomedical Engineering Design Education Program is to prepare innovative and
entrepreneurial biomedical engineering professionals who possess state-of-the-art product
development skill sets and best practices relied upon by the MedTech Industry to develop and
commercialize innovative medical device technologies to meet the global health care needs of
the 21st Century. In order to achieve this objective, two specific aims are proposed.
Specific Aim 1 intends to strategically tune selected biomedical engineering design courses and
program curricula to produce highly competent and high performing, innovative and
entrepreneurial MedTech product design and development team members and teams that meet
21st Century Workforce Needs. Proposed programmatic enhancements include (a) the
expansion of coverage of an existing BME 214 FDA regulatory course to include coverage of
emerging medical device technologies and applications, (b) the piloting of a junior level BME
300 design course that has been restructured to serve as a pre-capstone feeder to the yearlong
senior BME capstone design experience, (c) the assessment of team formation and team
performance in pursuit of high performance ‘Dream Teams’ (d) expansion of BME senior
capstone design to include a MedTech manufacturing foundation for all graduates of the BME
program, (e) supplemental support of capstone design projects having promising clinical impact
and commercialization potential of either Biomedical Devices and Biological Devices nature (e)
support to further develop one or two promising capstone projects having potential to have
significant clinical impact and commercialization potential.
Specific Aim 2 entail (f) the addition of a summer, contextual inquiry mini-workshop is planned
to help onboard BME students selected for a clinical immersion, as well as, (g) the creation of a
clinical immersion component to our BME design program for selected upper division BME
design students with partnering medical institutions that include the Mayo Clinic Arizona,
Phoenix Children’s, Barrow Neurological Institute and the Creighton University Medical School
at the Health Science Campus-Phoenix.

Public health relevance
Project Narrative The proposed Team-Based Design and Clinical Immersion Enhancements to the ASU Biomedical Engineering Design Education Program is to prepare graduates of the Harrington Biomedical Engineering program at ASU to meet the workforce needs of the MedTech industry. Graduates of the program will possess state-of-the-art product development skill sets and best practices relied upon by the MedTech Industry to develop and commercialize innovative medical device technologies that can effectively address the global health care needs of the 21st Century.